CATCH-UP: NCI ETCTN Pittsburgh Cancer Consortium (PCC)

ABSTRACT
This application is being submitted to request the addition of an Affiliated Organization(s) to the Early
Therapeutics Clinical Trial Network (ETCTN) UM1 Lead Academic Organization.
The Chao Family Comprehensive Cancer Center (CFCCC) of the University of California, Irvine (UCI) has
demonstrated to be a well performing site in the Create Access to Targeted Cancer Therapy for Underserved
Populations (CATCH-UP) program, enrolling a total of 34 patients with nearly half (48%) coming from diverse
patient populations (e.g. Latino, Asian and underserved areas). With the success of CFCCC’s participation in
CATCH-UP, CFCCC will be integrated into the Pittsburgh Cancer Consortium (PCC), providing access for their
patients to all ETCTN trials.
The PCC will integrate CFCCC by providing regulatory support, data coordination and reporting of adverse
events and outcomes on the studies led by UCI investigators. In addition, the PCC will support CFCCC through
development of concepts and leadership in ETCTN trials. Conversely, CFCCC will use their experience and
success in the CATCH-UP program to deploy best practices in underserved patient accrual in the PCC.

Public health relevance
NARRATIVE The overarching goal of the NCI Experimental Therapeutics Clinical Trials Network (ETCTN) is to enhance and facilitate the efficient and comprehensive conduct of early-phase clinical trials of NCI Investigation New Drug (IND) agents. The University of California, Irvine (UCI) Chao Family Comprehensive Cancer Center (CFCCC) will be integrated into the Pittsburgh Cancer Consortium (PCC) Lead Academic Organization which currently includes the UPMC Hillman Cancer Center (HCC) and the Montefiore Einstein Cancer Center (MECC). The long-term goal is to guide the development and conduct of early-phase clinical trials that may have the potential to change the standard of cancer care in the U.S. and worldwide.